Investigating a hemagglutinin mediated molecular mechanism of avian influenza A virus host tropism

Project Summary
Zoonotic transmission of avian Influenza A virus (IAV) to humans poses a pandemic threat. Recent
transmission of avian IAV to dairy cattle, and to dairy farm employees emphasizes the importance of identifying
molecular mechanisms that regulate zoonotic events. It is thought that the IAV envelope glycoprotein,
hemagglutinin (HA), must adapt its receptor specificity to bind α2,6-linked SA that predominates the human
upper airway to initiate infection. However, recognition of α2,6-linked SA by HA is insufficient for avian H5N1
IAVs to enter human cells, indicating that other adaptations are necessary for zoonotic transmission to occur.
Although evidence suggests that the pH and temperature sensitivity of HA are important factors that govern
host tropism of IAV, a molecular mechanism that explains the temperature and pH dependence is missing. To
define the pH and temperature dependence of HAs pre- to post-fusion conformational change, we first focused
on visualizing conformational dynamics of HA with single-molecule FRET (smFRET). Preliminary data reveal
that under neutral pH and room temperature conditions, the head domains of A/Vietnam/1194/2004 (H5N1)
(VN04) HA, HA1, undergo a breathing motion where the heads are either fully caged, or partially uncaged. At
pH8.0 HA spends 50% of the time in the fully caged conformation and 50% of the time in the partially uncaged
conformation. Decreasing the pH to 6.5 shifts the equilibrium to where HA spends 30% of the time in the fully
caged conformation and 80% of the time in the partially uncaged conformation. These data allow us to
establish a conformational phenotype for HA where can determine the pH and temperature dependence of a
given conformational phenotype. Thus, the central hypotheses of this proposal are that (1) the regulation of the
pre- to post-fusion conformational change of avian HA is differentially regulated by pH and temperature
compared to human adapted HA and (2) this difference in regulation directly affects the fusogenic function of
HA. Experiments performed in Aim 1 will characterize the pH and temperature dependence of HAs
conformational phenotype by monitoring conformational dynamics of HA at pH 8.0, pH 6.5, and pH 5.5 as well
as at room temperature and 37°C. I will implement the smFRET for three HA serotypes: A/Vietnam/1194/2004
(H5N1) (VN04), A/California/07/2009 (H1N1) (CA09) and A/Hong Kong/1/1968 (H3N2) (HK68). Furthermore,
mutations that alter pH and temperature stability will be characterized to evaluate a molecular mechanism that
can explain the differences in the conformational phenotype between the different HA serotypes. Aim 2 will
characterize the pH and temperature dependence on HA-mediated membrane fusion by monitoring the extent
and rates of fusion of HA pseudo-typed virus with the three previously mentioned HA serotypes. Additionally,
the same pH and temperature stability mutations will be used to assess their impact membrane fusion.
Collectively, these data will reveal a mechanism that explains the zoonotic transmission potential of IAV and
help improve genetic surveillance efforts to identify variants of concern.

Public health relevance
Narrative With the use of smFRET and a bulk fusion assay, this application proposes to (1), characterize the early dynamic events of pH-triggered conformational changes of influenza A virus (IAV) hemagglutinin (HA) and (2), characterize the extent to which the regulation of the pre- to post-fusion conformational change is different between avian HA serotypes and human adapted serotypes. These experiments will lead to a better understanding of fusion mechanism of HA but will also reveal differences in the regulation between avian HA serotypes and human adapted serotypes. Identifying differences in the regulation of avian HA and human HA will help build a mechanism to describe the host tropism of IAV with the goal of improving genetic surveillance to identify variants of concern.